Mechanisms of synergistic regulation of biliary inflammation and fibrosis

The risk of liver diseases due to alcohol and toxin abuse and hepatitis viruses in US Veterans is increasingly
high and is one of the most common reasons for hospitalization and mortality. Hepatic fibrotic disease represents
one of the largest groups of disorders for which there is no effective therapy and thus denotes a major unmet
medical need. Often the only option for patients with liver fibrosis is organ transplantation. Chronic liver diseases
include cholangiopathies that target cholangiocytes such as Primary Sclerosing Cholangitis (PSC) which is
characterized by biliary proliferation, inflammation and progressive fibrosis. Unrestrained cholangiocyte
proliferation can develop into cancer of the bile ducts (i.e., cholangiocarcinoma, CCA) and patients with PSC are
more susceptible to development of CCA. Further, cholangiocytes display a senescent phenotype during PSC
which may contribute to inflammation and further influence hepatic fibrosis by activating hepatic stellate cells
(HSCs). It has been shown that damaged cholangiocytes secrete senescence-associated secretory phenotypes
(SASP). Mast cells (MCs) are important in mediating numerous pathologies including liver diseases, but are
found at very low numbers in normal, homeostatic livers. Infiltrating hepatic MCs are found near damaged
intrahepatic bile ducts and activated HSCs. In unpublished data, we have found that damaged, senescent
cholangiocytes induce MC migration during non-alcoholic fatty liver disease. Further, senescent cholangiocytes
secrete factors like stem cell factor (SCF) and interleukins that are known to be chemoattractants for MCs,
inducing migration. Following migration and activation, MCs release mediators including large amounts of
histamine that stimulates cholangiocyte proliferation and fibrosis. The rationale for our proposal is built upon
previously published data from our lab and others showing that MC infiltration increases in PSC and CCA patients
along with rodent models of liver damage, and MC infiltration positively correlates with increased fibrosis.
Additionally, normal wild-type mice (typically very few hepatic MCs) injected with cultured MCs display increased
biliary damage, inflammation and hepatic fibrosis, all of which are key features of PSC. Using a model of PSC
(Mdr2-/- mice) we generated a double knockout mouse (DKO) by breeding Mdr2-/- with mice lacking histidine
decarboxylase (HDC-/-). DKO mice (few to no MCs) have decreased biliary damage, inflammation and hepatic
fibrosis. Further, upon reintroduction of MCs into DKO mice, we find a striking increase in damage and fibrosis
that mimics Mdr2-/- mice, which was reversed when MCs lacking TGF-β1 signaling were used demonstrating a
key role for MCs in PSC. Finally, inhibition of MC-derived histamine decreases biliary damage and hepatic
fibrosis in models of cholestatic liver injury, PSC and CCA suggesting that modulation of MCs mediators may
prove therapeutic. We propose the working hypothesis that senescent cholangiocytes induce MC
migration during PSC and modulation of MC-derived TGF-β1 or FXR regulates ductular reaction and
hepatic fibrosis via biliary senescence. We propose the following specific aims (SAs): (SA1) Senescent
cholangiocytes recruit MCs to the liver by secretion of specific SASPs during PSC; (SA2) MCs promote liver and
biliary damage, inflammation and hepatic fibrosis resembling PSC in normal mice or mice lacking MCs; and
(SA3) MCs exacerbate biliary damage and hepatic fibrosis during PSC via cellular crosstalk between histamine,
TGF-β1 and FXR.

Public health relevance
The research program proposed herein is significantly relevant to the VA mission and its successful completion will likely benefit Veteran patients. The risk of liver diseases due to alcohol and toxin abuse in US Veterans is increasingly high and is one of the most common reasons for hospitalization, morbidity and mortality in US Veterans. Scientific interest in cholangiocytes (cells lining the biliary tract) is due to the fact that these cells are the target cells in cholangiopathies primary sclerosing cholangitis (PSC), which result in fibrotic, scarred livers. Mast cells (MCs) are immune cells that infiltrate the liver during damage and promote disease progression including increasing fibrosis by interacting with damaged cholangiocytes. Often the only redress for patients with hepatic fibrosis is transplantation; since the supply of organs is insufficient to meet the demand, patients often die while waiting to receive suitable organs. Targeting the interactions between MCs and cholangiocytes will likely lead to new therapies for US Veterans suffering from liver diseases.